Colocalization of gene expression and microscale tissue strains in live tendon explants using barcoded biosensors

Project Summary
Tendinopathy is a chronic degenerative disease that occurs in response to tendon overuse (i.e., fatigue loading).
In addition to mechanical damage, tendon fatigue loading induces the expression of catabolic proteases,
inflammatory cytokines, and the accumulation of abnormal matrix components (e.g., cartilaginous, fat, and
calcium deposits), which further weaken the tissue and drive the progression of degeneration. Understanding
why tendon cells fail to restore the tissue structure and instead exacerbate degeneration is critical for preventing
tendinopathy. The prevailing hypothesis is that the counterproductive cellular response to tendon overuse results
from mechanotransduction of altered biophysical stimuli resulting from local tissue damage. However, there is
a fundamental lack of knowledge regarding tenocyte mechanotransduction in the native tissue
environment and, therefore, whether altered biophysical stimuli are responsible for tendon degeneration. To
address this knowledge gap, the objective of this proposal is to develop a live tissue explant model enabling
simultaneous spatiotemporal measurement of local mechanical stimuli and cellular gene expression during
tendon fatigue loading. By colocalizing the tenocyte response with the mechanical stimuli present in the native
cellular microenvironment, we can directly test whether mechanotransduction is responsible for the negative
cellular response observed with tendon degeneration. The critical technological obstacle to achieving this
goal is the development of a biosensor that can dynamically detect the spatial distribution of cellular gene
expression in tendon explants. Endogenous fluorescent reporters are limited by the time and cost of generating
a transgenic mouse for specific genes of interest. Alternative biotechnologies require cell transfection, which is
inefficient in tissues with a dense extracellular matrix. Therefore, we will investigate whether gold nanorods,
which are internalized via endocytosis, can deliver fluorescently labeled oligonucleotide probes to detect cellular
gene expression in tendon explants. In Aim 1, we will optimize the design of gold nanorod-locked nucleic acid
biosensors and validate their sensitivity and spatial accuracy in measuring mechanosensitive genes in live
tendon explants. Additionally, we will establish a barcode strategy with FRET-pair probes and a spectral
unmixing algorithm to simultaneously measure up to ten target genes. In Aim 2, we will use this technology to
determine whether the degenerative cellular response to tendon fatigue is spatially associated with changes in
local mechanical stimuli (i.e., strains). This project is innovative because our results will identify the stimuli
mediating the negative cellular response to tendon overuse and help develop novel therapies for preventing
degeneration. Additionally, we will establish the ability to measure spatiotemporal distributions of gene
expression in live tissue explants with a dense extracellular matrix (e.g., tendon). This technology will be ground-
breaking for musculoskeletal research since explant models are commonly used to study musculoskeletal
tissues and existing techniques requiring cell transfection are not effective due to the dense extracellular matrix.

Public health relevance
Project Narrative While fatigue loading is a primary cause of tendon degeneration, the mechanisms that induce a degenerative cellular response to local fatigue damage is unknown. The goal of this project is to develop a live tendon explant model using gold nanorod biosensors that enable simultaneous spatiotemporal measurement of gene expression and local mechanical stimuli in the native tissue environment during fatigue loading. This will not only identify the biophysical stimuli responsible for tendon degeneration but also provide a breakthrough more broadly in the study of musculoskeletal tissue explants and disease.